Biomarker-Based Diagnostic Algorithms To Prevent, Detect And Guide Treatment Of Kidney Disease In Persons Living With HIV

ABSTRACT
Our strategies for preventing, detecting, and monitoring kidney disease in people living with HIV (PLWH)
have lagged far behind the incredible advances in HIV treatment and management over the past decades.
Despite their proven limitations for diagnosing chronic kidney disease (CKD), the serum creatinine and the
urine protein concentration remain the mainstays of kidney health monitoring for PLWH. While clinical kidney
diagnostic testing has stagnated, PLWH face an increasing myriad of insults to the kidneys, including
metabolic and vascular risk factors, chronic inflammation, direct viral toxicity, and potentially nephrotoxic
medications. Consequently, CKD has accelerated as a cause of morbidity and mortality in PLWH.
Over the past decade, our pioneering work in PLWH has shown that biomarkers of tubule health yield
significantly more diagnostic and prognostic information than could be obtained by conventional kidney health
assessments. This competitive renewal application will build upon this prior work to fulfill our mission of
fundamentally changing how kidney disease is detected, diagnosed and monitored. This proposal strategically
addresses the most challenging aspects of CKD diagnosis and treatment, and will provide the evidence
needed to advance kidney biomarker-based diagnostic algorithms into clinical practice.
Successful completion and clinical translation of our Aims will allow clinicians to achieve the following major
goals. 1) Among PLWH with acute elevations of the serum creatinine, we will be able to distinguish whether or
not the individual has true kidney injury and to identify the patterns of injury that forecast the likelihood of
kidney function recovering or worsening during subsequent follow-up (Aim 1). 2) For each modifiable kidney
disease risk factor in PLWH, we will be able to monitor the impact of improvements and deteriorations in risk
factor control on the kidney, using a tailored set of surrogate biomarkers (Aim 2a). 3) We will use a time-
updated algorithm that will integrate dynamic changes in risk factors and kidney biomarkers to prognosticate
longitudinal changes in risk for rapidly progressive kidney disease, for each individual PLWH (Aim 2b). 4) For
the many PLWH with myriad exposures that threaten or lower risk for progressive kidney disease, we will
utilize a novel biomarker-based monitoring algorithm to identify and prioritize each risk factor based on its
Bayesian probability of causing the observed pattern and severity of kidney damage. Despite these ambitious
goals, this proposal is both feasible and efficient as we will use biospecimens and clinical data that have been
or will be collected among PLWH in the Multicenter AIDS Cohort Study (MACS), the Women’s Interagency HIV
Study (WIHS), the MACS-WIHS Combined Cohort Study (MWCCS), and the Predictors of Acute Renal Injury
Study (PARIS) cohorts. The study investigators are a multi-disciplinary team of experts who bring enormous
enthusiasm, experience and commitment to the proposal and will guarantee its success.

Public health relevance
PROJECT NARRATIVE Kidney disease is increasingly common in people living with HIV infection, but routine clinical tests are insensitive and cannot determine the specific causes. The findings from these projects will help clinicians to monitor kidney health and detect and treat earlier stages of kidney disease, which would allow unique opportunities for individualized prevention and treatment strategies in this high-risk population.